Project 1: Cellular requirements for Pol theta

PROJECT 1 SUMMARY
Loss of Pol θ is tolerated in normal cells but is lethal in many cancers, making it an attractive target for cancer
therapy. Unfortunately, the cellular contexts that drive this synthetic lethality still remain unclear. Here we will
investigate cellular requirements for repair by mammalian DNA polymerase θ (Pol θ), the defining enzyme for
repair of DNA double-strand breaks by polymerase theta-mediated end joining (TMEJ). Project 1 (“Cellular
requirements for Pol θ”) is part of a Program Project titled, “Polymerase theta, genome instability, and cancer”.
We will address the significance of recently described interactions between Pol θ and elements of the genome
replication machinery, including Pol δ and PCNA, in Aim 1. We will in Aim 2 investigate how cellular regulation
of Pol θ activity effects requirements for Pol θ, focusing on perturbations relevant to cancer therapy and the DNA
damage response. We will explore in Aim 3 the molecular determinants for Pol θ requirement in cellular
resistance to inhibitors of the type 1 Topoisomerase, an agent used in chemotherapy. This project together will
extend recent exiting work from our team to characterize mechanisms behind Pol θ activity in response to
replication stress, and how this differs relative to mechanisms for repair of chromosome breaks generated by
other sources.

Public health relevance
PROJECT 1 NARRATIVE We seek to understand the mechanistic differences between Pol θ function in repair of conventional two ended chromosome breaks (e.g. generated by ionizing radiation) and chromosome breaks generated by replication stress, as the latter may be an especially important target for cancer therapy This will include investigations into the relevance of Pol θ interaction with the replicative Pol δ, regulation of Pol θ activity, and its role in conferring resistance to inhibitors of Type Topoisomerases, a replication-stress causing drug used for chemotherapy.